Advancing Rigorousness and Reproducibility for High Throughput Data

Reproducibility is a fundamental to good science, and is lacking in many scientific studies to
date. This slows the progress of research positively impacting biological, health, regulatory, and
medical challenges. The Massive Analysis Quality Control Society (MAQC Society) seeks to
enhance reproducibility and rigorousness specifically of high throughput data. The objective of
the MAQC Society is to discuss, study, and encourage reproducible science and quality control
for analysis of large datasets originating from emerging technologies. To foster discussions,
present research, and train the next generation of reproducible scientists, the MAQC Society
has an annual meeting. The past three have been very successful, attracting 150-200 domestic
and international attendees split roughly equally between academia, government, and the
private sector. All attendees are exposed to a range of research important to FDA and NCTR.
Due to our diversity of attendance, our annual meeting helps attendees network, discuss across
sectors, and set up cross-functional projects to interrogate and advance reproducible science.
This society is highly focused on training up and coming scientists. The MAQC Society is proud
to see that many students and postdoctoral fellows attend. Every year, the agenda features a
poster session as well as a “lightning round” of abstract selected presentations. In addition to
the next generation, MAQC Society meetings attract reproducibility key opinion leaders. Owing
to the small conference of the annual conference, newer scientists have the opportunity to
mingle with these senior leaders. To continue with our mission of creating a community forum
for presentation and discussion, the MAQC Society is applying for funding for the next 5 annual
conferences. This funding will support travel and accommodation expenses for keynote
speakers, student poster and presentation awards, student travel grants, and student-related
conference activities, and workshops around topics important to reproducible science.

Public health relevance
The MAQC Society seeks to enhance reproducibility, and quality control across high throughput biomedical research. Through the annual society conference, the MAQC Society promotes education, best practices, collaboration, and idea exchange across sectors, training levels, and communities. Educating scientists around the world about ways to enhance the rigorousness of their research will enable more successful translation of research to positively impact patient lives.